BIOCLIN: A precision medicine platform to support biomarker-driven clinical trials

PROJECT SUMMARY
Genomic biomarkers enable precision medicine by matching patients to their optimal treatments.
Mutational biomarkers are used as standard practice for oncology patients to assign them to treatment.
However, mutations don’t have the predictive power for several therapies, including immunotherapy, which
results in complete and durable responses for a subset of cancer patients. RNA sequencing (RNAseq) has
been shown to improve accuracy over mutations in preclinical studies, including being able to predict response
to immunotherapy, and even mutational status. The global RNAseq market is currently estimated at 9 billion
dollars and is expected to grow at an annual rate of 10% from 2023 to 2030. The number of RNAseq
biomarker trials has already doubled in 2020-2023 compared to 2010-2020, based on data in clinicaltrials.gov.
RNAseq biomarkers currently face three major challenges: (1) bioinformatics analysis to translate signatures,
cutoffs, etc. for application in the clinic, (2) regulatory issues with reproducibility and clinical validation, and (3)
lack of software platforms to provide clinical trial support for biomarkers. There is currently no commercial
software to support patient selection based on their RNAseq profiles at baseline, to the best of our
knowledge.
We have developed a prototype software suite, BIOCLIN, for an ongoing multi-site phase II
RNAseq biomarker trial in kidney cancer (NCT05361720). It includes analysis of RNAseq data for each
patient on the fly, run machine learning models and display gene signature scores per patient in an easy to
use, intuitive user interface. Our goal is to develop our prototype into a commercial product with
additional functionality that can be used to rapidly deploy platforms to support biomarker-based trials.
In this Phase I proposal, we will (1) conduct extensive user research to understand the needs of
investigators for running RNAseq based biomarker trials and develop a roadmap for our BIOCLIN app (2)
develop methods to translate preclinical signatures for clinical use and implement a variety of machine learning
modules to be used for biomarker development, and (3) develop a robust cloud-based backend infrastructure
to enable rapid deployment of custom biomarker platforms at a price point to make such trials economically
feasible for investigators.
In Phase II we plan to implement methods to tackle regulatory challenges, a robust data security
framework, an improved user interface and a cloud agnostic backend. Our proposal, if successful in obtaining
funding, will address the gap in precision medicine by enabling investigators to test RNAseq biomarkers in
clinical trials, which will undoubtedly have an impact on patients.

Public health relevance
PROJECT NARRATIVE RNA sequencing data yield powerful biomarkers for precision medicine, however there is a gap in the lack of software platforms to facilitate testing such biomarkers in the clinic. Our proposal is to develop methods to translate preclinical RNAseq biomarkers for clinical use, and to develop a comprehensive set of backend cloud-based infrastructure to enable rapid deployment of software platforms to support biomarker-driven trials. Our platform will address a much-needed solution to advance precision medicine.